The role of HPF1 in radiation and genotoxic cancer therapy

PROJECT SUMMARY/ABSTRACT
Cancer radiation therapy generates reactive oxygen species (ROS), which cause both single and double-strand
DNA breaks that rapidly recruit and activate Poly ADP-ribose polymerase 1 and 2 (PARP1&2). Dual-specificity
inhibitors for PARP1 and 2 (PARPi) are promising treatments for BRCA1 or 2-deficient cancers, alone or in
combination with radiation. Progressive fatigue, a common side effect of radiation therapy, is often associated
with anemia. Severe anemia and the related therapy-induced MDS/AML are also the most common dose-limiting
toxicity of PARPi, causing the FDA to withdraw two PARPi from maintenance therapy in 2022. But why radiation
and PARPi preferentially target erythropoiesis than other genotoxic therapies (e.g., cisplatin or nucleoside
analogs) remains elusive. A major clinical challenge for combination therapy is minimizing bone marrow toxicity.
Active PARP1&2 uses NAD+ as a substrate to covalent link ADP-ribose (ADPr) to themselves and other proteins
to generate Poly-ADPr (PAR) chains. While all negatively charged, PAR can come in many different flavors.
PARP1 and 2 can ribosylate substrate proteins on different residues - Serine, Glutamine, and Aspartate. PAR
chains can be short (a few ADP-riboses) or long, straight, or branched. Histone PARylation Factor 1 (HPF1) is
a newly discovered PARP1&2 regulator. HPF1 is essential for initiating serine PARylation by PARP1&2 and
suppresses PAR chain elongation. Alteration in the PAR chain structure and organization could affect some but
not other PAR-binding proteins (readers), leading to different biological impacts. In preliminary studies, we
showed that 1) PARPi-induced acute hematological toxicity requires the presence of PARP1 protein; 2) HPF1 is
critical for both PARP1 and PARP2 auto-PARylation during normal replication and in DNA damage response; 3)
Yet, HPF1 is dispensable for hematopoiesis and murine development. 4) Hpf1/Parp1 double knockout (DKO)
mice have no measurable development defects. 5) But, Hpf1/Parp2 DKO mice with Parp1 expression died
embryonically with severe anemia. Based on these and other data, we hypothesize that HPF1 might be a
promising target for cancer therapy by balancing DNA damage response vs. normal hematological
function. We further hypothesize that HPF1 cooperates with PARP2 to regulate PARP1 activation and
dynamics during normal hematopoiesis with implications in radiation and PARPi-induced bone marrow
toxicity. To test this, we propose to determine 1) how Hpf1 and Parp2 collaborate to regulate Parp1 dynamics
at damage sites; 2) how HPF1 regulates the substrate and PAR chain structural specificity upon DNA damage;
3) how HPF1 deletion or inactivation (E284A) causes hematopoietic failure by increasing PARP1 protein
accumulation. The results will uncover previously unrecognized structural functions of Hpf1 in radiation and
PARPi-induced hematological toxicity, address the substrate and PAR chain specificity of PARP1 activation
during normal replication, radiation, and cancer therapy, and eventually provide the strategy to mitigate the
hematological toxicity.

Public health relevance
PROJECT NARRATIVE Our proposal utilizes mouse genetic, live-cell imaging, flow cytometry, biochemistry, and molecular biology approaches to identify 1) how Hpf1 and Parp2 collaborate to regulate Parp1 dynamics at DNA damage sites; 2) how HPF1 regulates the substrate and PAR chain structural specificity; 3) how HPF1 prevents PARP1 trapping induced hematopoietic failure promoting PARP1 release. The goal is to understand the complexity of radiation and replication-induced PARylatio and develop strategies (e.g., targeting Hpf1 compound catalytic site) to mitigate bone marrow toxicities in radiation and PARPi treatment.